Modeling Pathways of Early Growth Dysregulation at the GEJ

PROJECT SUMMARY
Cellular biology of the human gastroesophageal junction cardia (GEJ-cardia) has been notoriously difficult to
study, in particular due to a lack of biologically relevant GEJ-cardia-specific disease models. Based on known
early genetic events in GEJ-cardia neoplasia, we generated wild-type (WT) and TP53/CDKN2A dual-knockout
(DKO) 3-dimensional (3D) human GEJ-cardia-derived organoids using CRISPR-Cas9 genome editing. Notably,
DKO organoids grew faster, became larger, exhibited de novo intestinal, metaplastic and dysplastic morphology,
and consistently grew as xenografts in vivo. Interestingly, 2-D MALDI mass spectrometric imaging revealed a
markedly abnormal lipidomic profile in DKO organoids, with platelet-activating factor (PTAF) and free fatty acids
(FFAs) among the most-upregulated lipids. Intriguingly, several of these FFAs (stearic acid, lauric acid, cyclo
acid, oleic acid, and palmitate) function as known ligands that stimulate HNF4A, a centrally important master
transcription factor (MTF) implicated during early GEJ-cardia neoplastic evolution.
We hypothesize that dysregulated FFA metabolism, acting via a novel lipid-epigenome crosstalk featuring MTF
hyperactivation, causes abnormal growth, proliferation and differentiation at the human GEJ-cardia. This
hypothesis will be tested by two Specific Aims. In Aim 1, we will first assess the biological effects of PTAF-
PTAFR signaling in our early GEJ neoplasia organoid model, using either loss- or gain-of-function approaches,
followed by an examination of phenotypes, morphology, and differentiation of GEJ-cardia organoids. Similarly,
potential functions of candidate FFAs will be interrogated in GEJ-cardia organoids. Furthermore, we will establish
the in vivo etiologic role of PTAF-PTAFR signaling as well as candidate FFAs in early GEJ-cardia neoplasia. In
Aim 2, we will explore a novel crosstalk between lipid metabolism and epigenomic reprogramming by
investigating the functional contributions of FFAs and PTAF to the epigenomic activity of HNF4A. Direct binding
of FFAs and PTAF to HNF4A will be measured by competitive radiometric binding assays. The functional
regulation by HNF4A of GEJ-cardia chromatin accessibility and activity will be interrogated using a palette of
epigenomic sequencing approaches. Finally, we will perform spatial quantification of the abundance of HNF4A-
activating FFAs and PTAF in both GEJ-cardia organoids and primary patient samples by conducting advanced
histopathology-guided MALDI imaging analyses.
These efforts in toto promise to define biological drivers promoting early GEJ-cardia neoplastic evolution and to
elucidate a novel crosstalk between lipid metabolism and epigenomic reprogramming, thereby discovering
precise molecular mechanisms underpinning GEJ-cardia dysplasia and early neoplastic transformation.
Moreover, this project has the potential to uncover and validate candidate approaches toward prevention and
early intervention in GEJ-cardia neoplastic evolution by targeting PTAFR, which may ultimately be effectively
blocked by an FDA-approved pharmacologic antagonist in human patients.

Public health relevance
Project Narrative The current application will test the hypothesis that dysregulated Platelet Activating Factor (PTAF) and free fatty-acid (FFA) metabolism, via a novel epigenetic crosstalk featuring aberrant HNF4A transcription factor activation, is involved in growth dysregulation and early neoplastic evolution in cardia columnar cells at the human gastroesophageal junction (GEJ-cardia). This hypothesis will be tested by blocking the PTAF and FFA- HNF4A pathways, with lipidomic profiling in a human organoid model system and in human GEJ-cardia samples.